THERAPY OF PRECOCIOUS PUBERTY WITH GNRH ANALOGS

The physiologic and hormonal changes of puberty impair insulin action. This protocol examines the kinetic mechanisms underlying this alteration in insulin responsiveness.